Regulation of intestinal barrier by E. coli curli fibrils

DESCRIPTION (provided by applicant): Amyloids, a common component of the biofilms of bacteria, are produced by the members of Bacteriodetes, Firmicutes and Proteobacteria. Recently, we have shown that curli, an amyloid found within the biofilms of enteric bacteria, is recognized by the innate immune system through Toll-like receptor 2 (TLR2)/TLR1 complex. E. coli Nissle 1917 (Nissle) was isolated by the army surgeon Dr. Alfred Nissle from the feces of a soldier who did not develop diarrhea during a severe Shigella outbreak during World War I. Since then many studies investigated the potential use of this organism for probiotic therapy in Inflammatory Bowel Diseases (IBD). Clinical trials have shown that treatment with EcN was as efficient as the standard medication in preventing the relapse of Ulcerativ Colitis (UC). Following studies have discovered that Nissle reinforces the intestinal epithelial barrier function. Furthermore, TLR2 activation by Nissle has been shown to have immunomodulatory effects in the gastrointestinal tract. Nonetheless, the mechanisms by which EcN induces the latter affects remain unknown. The objective of this application is to investigate the contribution of bacterial amyloids to host intesinal immune responses. We hypothesize that the detection of bacterial amyloids via TLR2 in the gastrointestinal tract enables epithelial cells to serve as sentinels for bacterial translocation fom the gut lumen and respond by augmenting the epithelial barrier. We will test this hypothesis by studying the immunomodulatory function of curli fibrils produced by the commensal organism Nissle.

Public health relevance
PUBLIC HEALTH RELEVANCE: Bacteria form biofilms to protect self from environmental insults in various niches including the gastrointestinal tract. Here, we will investigate the immunomodulatory function of bacterial amyloid fibrils, a common component of bacterial biofims, produced by the commensal organism E. coli Nissle 1917 on the gut epithelium. We expect that the outcome from the proposed studies will reveal new concepts relevant for host-microbe interactions and provide new insights into mechanisms of immune homeostasis at the mucosal surface. __SpecificAimsTextDelimiter__ 2. Specific Aims Amyloids are a common component of the biofilms of bacteria that belong to Bacteriodetes, Firmicutes and Proteobacteria, the phyla found in the gastrointestinal tract (17). Recently, we have shown that curli, an amyloid found within the biofilms of enteric bacteria, is recognized by the innate immune system through Toll- like receptor 2 (TLR2)/TLR1 complex (27-29). TLR2 has been shown to control the intestinal epithelial barrier by improving tight junctions through a PI3K-Akt pathway to balance mucosal homeostasis against inflammation (5). E. coli Nissle 1917 (Nissle) was isolated by the army surgeon Dr. Alfred Nissle from the feces of a soldier who did not develop diarrhea during a severe Shigella outbreak during World War I. Since then many studies investigated the potential use of this organism for probiotic therapy in Inflammatory Bowel Diseases (IBD) (21- 23). Clinical trials have shown that treatment with Nissle is as efficient as the standard medication in preventing the relapse of Ulcerative Colitis (UC) (16). Further studies have discovered that Nissle reinforces the intestinal epithelial barrier function. Furthermore, TLR2 activation by Nissle has been shown to have immunomodulatory effects in the gastrointestinal tract (11, 24). Nonetheless, the mechanisms by which Nissle induces the latter effects remain unknown. Our long-range goal is to elucidate the role of amyloids in human health. The objective of this application is to investigate the contribution of bacterial amyloids to host intestinal immune responses. Our central hypothesis is that the detection of curli amyloid fibrils via TLR2 by epithelial cells augments the epithelial barrier and limits bacterial translocation into the lamina propria in the gut. We will test this hypothesis by studying curli fibrils produced by the commensal bacterium Nissle. Our hypothesis has been formulated based on our preliminary data showing that (i) curli fibrils are recognized by the TLR2/TLR1 complex (ii), in vitro stimulation of epithelial cells by curli fibrils improves the epithelial barrier permeability through TLR2/PI3K pathway, (iii) curli fibrils are the predominant TLR2 ligand on E. coli cells, and (iv) Nissle expresses curli fibrils. The rationale by which curli fibrils stimulate innate immune responses will lead to a better mechanistic understanding of how commensal bacteria including Nissle promote intestinal barrier health. We are particularly well prepared to perform the proposed studies since we have generated many tools to study the function of bacterial amyloids in our lab. We plan to test our hypothesis and fulfill the objectives of this application by pursuing the following specific aims: 1. Determine the mechanisms by which the intestinal epithelial cells respond to curli fibrils produced by E. coli Nissle 1917 2. Determine the immune responses to curli amyloid fibrils produced by E. coli Nissle 1917 in the gastrointestinal tract The proposed work will explore for the first time the role of bacterial amyloid fibrils of biofilms as inducers of innate immune responses in the gastrointestinal tract. There are currently no reports in the literature regarding this topic, which illustrates the pioneering character of this application. It is our expectation that the successful completion of this study will help us generate enough preliminary data to pursue this exciting and novel project.